Postdoctoral Training Program in Stress and Trauma

This is a competing renewal application for funding to support a postdoctoral training program
aimed at producing clinical researchers who are qualified to be independent investigators
studying PTSD and related consequences of traumatic stress. The application proposes to train
four postdoctoral fellows during each year of the five year award, with a total of 8 fellows
completing the two year fellowship program and 2 fellows completing one year of the program
during the proposed award period. The training program is housed within VA Boston Healthcare
System and is affiliated with Boston University School of Medicine. The program is designed to
provide training in five core domains relevant to the next generation of clinical scientists who
investigate topics related to traumatic stress. These domains include a) neuroimaging and
clinical neuroscience; b) molecular biomarkers and genetics; c) assessment, diagnosis, and
epidemiology; d) treatment development and optimization; and e) implementation and
dissemination. Core faculty have established programs of research, are highly productive, are
active collaborators across domains of expertise, and have an extensive record of successful
mentorship. Support faculty include junior investigators who serve in an apprentice role as
supervisors and mentors. Faculty affiliations with other programs at both primary institutions
afford additional training and research opportunities. The training program continues its
commitment to recruit diverse candidates and to provide training in research with diverse
populations. The application provides detailed information on the proposed training program and
the success of the training program to date.

Public health relevance
Posttraumatic stress disorder (PTSD) is a prevalent, chronic, and disabling condition. The goal of the proposed training program is to provide advanced training and professional development experiences to postdoctoral fellows who will comprise the next generation of expert clinical scientists in this important public health area.